SUPPORT FOR THE EPIDEMIOLOGY BRANCH, DAIDS

Services to support research activities for the objectives of this contract are to provide the Epidemiology Branch, DAIDS, NIAID as specified below: 1. Plan and conduct scientific meetings and conferences. 2. Provide conference call support services. 3. Provide a documents repository. 4. Provide graphics and design services. 5. Provide scientific literature services. 6. Provide directory services. 7. Prepare annual reports and an operations manual. A vital and major portion of the research activities of the Epidemiology Branch is the completion of epidemiology protocols through numerous meetings of contract investigators.